Roles for Transcription in Antibody Diversity

Our study pointed out an unexpected fence function of MARsEmu regions in limiting the error-prone repair machinery to the variable region of Ig gene loci. We will next determine why mutations stop after 1 kilobase in the variable region. For this, we generated a knockin mouse strain with a defined V-D-J1 gene placed into the IgH locus. Homozygous mice are being bred to determine which transcription proteins are recruited to this region by ChIP analysis. These results will help determine how activation induced deaminase regulates transcription dynamics.